2014 ASME Summer Bioengineering Conference/World Congress of Biomechanics

DESCRIPTION (provided by applicant): The goal of this award is to help increase student attendance and participation at the 2014 joint meeting, known as the 16th ASME Summer Bioengineering Conference (SBC) and 7th World Congress of Biomechanics (WCB). This joint meeting will be held in Boston, MA, from July 6-11, 2014. The primary purpose of the SBC for the past 15 years has been to promote state-of-the-art research, collaboration, and scientific discourse in the broad field of bioengineering with focus on biomechanical engineering, encompassing molecular to tissue and organism-level approaches. This conference highlights students, promotes advancement in their education and furthers their careers towards becoming future leaders in bioengineering. Likewise, the quadrennial WCB brings together outstanding researchers from around the world to present and discuss the latest research in biomechanics and its application to human physiology and disease. Because of the plan to hold the 2014 World Congress in North America (which occurs every 12 years), it was decided that it would be most effective and maximize attendance at both meetings if the 2014 SBC and WCB were cohosted, with coordination of all aspects of meeting organization. The award will allow the conference organizers to reduce student registration fees for 100 student attendees. All presentations are documented in an extended abstract format and compiled in a CD that is distributed to all registrants. Copyright is provided and an ISBN number issued to allow appropriate archiving of the conference material.

Public health relevance
PUBLIC HEALTH RELEVANCE: The 2014 Summer Bioengineering Conference (SBC) will be co-hosted with the 7th World Congress of Biomechanics (WCB) on July 6-11, 2014, at the Hynes Convention Center in Boston, MA. The primary purpose of this conference is to promote state-of- the-art research, collaboration, and scientific discourse in the broad field of bioengineering with a focus on cutting edge biomechanics. The primary aim of this proposal is to provide an opportunity for students to attend the conference so as to energize these future researchers and offer them opportunities to experience emerging biomedical technologies that apply across disciplines and to enhance their professional development at the 2014 SBC/WCB.